Respiratory effects of e-cigarette use among youth: a prospective, longitudinal investigation

PROJECT ABSTRACT
Electronic cigarettes (EC) remain the most commonly used product among high schoolers. Little is known
about acute and longitudinal respiratory effects of ECs. This novel study will contribute critical knowledge
needed to understand pulmonary functioning and respiratory effects among 150 youth who are exclusive-EC
(N = 100) or never-users (N = 50; EC or other tobacco products), using a longitudinal, multimethod design.
Youth will complete 5-laboratory assessments to provide a comprehensive assessment of respiratory health
(airway reactivity and inflammation; pulmonary functioning). Further, we will incorporate EC user topography to
assess the immediate acute effects of EC use on respiratory markers. Two weeks prior to laboratory
assessments youth will complete daily EMA and spirometry assessments to examine how the frequency and
quantity of EC use impairs acute pulmonary functioning. This Tobacco Regulatory K01 will provide much
needed evidence regarding the immediate and longitudinal effects of EC use, while providing valuable training
to a promising new investigator from leading experts in the field of tobacco regulatory science.

Public health relevance
PROJECT NARRATIVE E-cigarettes (EC) remain the most commonly used product among high schoolers. No studies have examined how EC use effects the respiratory health of youth, even though these factors are identified as an understudied and priority area of investigation by the FDA. The proposed study incorporates in-laboratory and ecological momentary assessment (EMA) methodology, as well as a battery of respiratory assessments to identify the effects of youth EC use.